Administrative Core

ABSTRACT/SUMMARY: Administrative Core
The Administrative Core of our proposed Stanford Center for Cancer Systems Biology (CCSB) will provide the
logistical support for all coordinated activities related to our Center. It will operate under an organizational
structure that facilitates communication and access across all components of our Research Center, other NIH
CSBC Research Centers, the NIH CSBC Program staff, and the proposed U24 Coordinating Center. Internally,
our CCSB will have an Executive Committee, Steering Committee, and Internal Advisory Board (IAB) to oversee
the scientific, training, and outreach activities of our Center and ensure that our overall goals and specific aims
are being met. Our Executive Committee will be led by our MPIs, who have successfully led our CCSB program
over the past five years, along with the support of our Center Data Manager, who will oversee the coordination
of the Biospecimen and Data Core and ensure overall management of data generation and pre- and post-
processing and sharing, and our Center Administrator, who will monitor and execute daily administrative center
operations. Our Steering Committee will be composed of the Core Leads and co-Leads, Project Leads and co-
Leads, and the Data Center Manager. The IAB will be available to provide our Center with scientific advice,
general evaluation, and address specific issues related to our annual site review. Additionally, we will establish
an External Advisory Board (EAB) of key advisors to benefit from their extensive experience relevant to complex
systems biology issues related to tumor-immune-stromal interactions in metastatic progression. In order to
expand our network of investigators, our Administrative Core will facilitate our proposed Intra-center Pilot Project
in Years 1-5 and Cross-Consortium Project in Years 2-5 of the program. Our Administrative Core will coordinate
the solicitation, application and review processes. These pilot projects will be evaluated and awarded based on
scientific merit with the aim of fostering new avenues of research aligned with the scientific theme of our
Research Center. The cross-consortium projects will be funded to increase research opportunities for
collaborative and interactive efforts among members of the consortium. The Administrative Core will commit to
promoting equity, diversity, and inclusion in the data science research environment and provide training
opportunities for minority and underrepresented communities. Finally, our Administrative Core will facilitate the
annual Scientific Review of progress on the research, training, and outreach goals of the Stanford CCSB by our
External Advisory Board and the National Cancer Institute.